Combining Brain Stimulation with Computerized Cognitive Training for MCI

PROJECT SUMMARY/ABSTRACT
The proposed K23 Award will support Dr. Stephanie Aghamoosa, PhD in launching an independent program of
research developing non-pharmacological interventions for the secondary prevention of dementia. Dr.
Aghamoosa is a clinical neuropsychologist whose long-term career goal is to become a federally-funded
investigator conducting large-scale clinical trials of non-pharmacological interventions that are clinically scalable,
widely applicable to patients, and that produce long-lasting cognitive and functional benefits. Need for this
research is significant and consistent with NIA’s Strategic Goal of identifying interventions to delay the
progression of cognitive decline. To achieve her career goal, Dr. Aghamoosa proposes to obtain advanced
training that builds upon her clinical specializations in health psychology and neuropsychology and foundational
research experiences focused on aging, Mild Cognitive Impairment (MCI), and Alzheimer’s disease (AD). The
proposed K23 training, development, and research activities will address remaining gaps, ensuring that Dr.
Aghamoosa has the skills and knowledge necessary to accomplish her Career Development Goals which are
to: 1) Become an expert in non-pharmacological interventions to improve cognition in MICI/AD, 2) Obtain
advanced training in clinical trial methodology for MCI/AD, 3) Become proficient in advanced statistical
techniques for clinical trials that incorporate digital health technology, and 4) Establish herself as an independent
NIH-funded investigator. Dr. Aghamoosa is an Assistant Professor in the Department of Health Sciences and
Research at the Medical University of South Carolina. She will be supported by an exceptional mentorship team
of experts in the areas relevant to her career goals and proposed research project: clinical trials in MCI/AD
(Benitez, Primary Mentor), cognitive rehabilitation interventions (Twamley, Co-Primary Mentor), non-invasive
brain stimulation (McTeague), longitudinal analysis of clinical trial data (Nietert), and digital health technology for
assessment of real-world function (Moore). Dr. Aghamoosa’s K23 research project builds upon her involvement
in her Primary Mentor’s ongoing work demonstrating cognitive enhancement from non-invasive intermittent theta
burst stimulation (iTBS) in people with MCI. In this K23 application, Dr. Aghamoosa proposes a new and distinct
line of work aimed at maximizing treatment outcomes through combining iTBS with computerized cognitive
training (CCT). The proposed Phase I clinical trial will randomize 50 people with MCI to iTBS+CCT or
iTBS+shamCCT to: Aim 1: Establish the feasibility and acceptability of combining iTBS with CCT in MCI. Aim
2: Determine the preliminary effect sizes of combining iTBS with CCT in MCI. Exploratory Aim: Identify potential
mediators and moderators of treatment response. These activities will prepare Dr. Aghamoosa to successfully
lead a program of high impact, rigorously designed clinical trials of non-pharmacological interventions for MCI.

Public health relevance
PROJECT NARRATIVE Mild Cognitive Impairment (MCI) is the pre-dementia stage characterized by the early cognitive and behavioral changes of neurodegenerative diseases, for which there are limited options for effective prevention or treatment. The goal of this project is to investigate whether a promising and clinically scalable form of non-invasive brain stimulation (3-day intermittent theta burst stimulation [iTBS]) can feasibly be combined with evidence-based computerized cognitive training (CCT) to enhance the effects of treatment on cognition and psychosocial function in MCI. The results of this study will inform future clinical trials seeking to maximize the benefits of iTBS through combination with behavioral interventions, with the long-term goal of developing a scalable, widely applicable, and efficacious treatment to prevent dementia.